Frailty, Strength, and Mobility in Older Hernia Patients: A Novel Abdominal Wall Physical Therapy Program

PROJECT SUMMARY ABSTRACT
The Frailty, Strength, and Mobility in Older Hernia Patients: A Novel Abdominal Wall Physical Therapy
Program study aims to understand the role of frailty to surgical outcomes and postoperative quality of
life (QOL) for older adults undergoing elective abdominal hernia repair (AHR). Additionally, we seek to evaluate
the feasibility and utility of a novel perioperative abdominal wall physical therapy (AWPT) for AHR patients
over 65. Current literature is scarce on the relationship of frailty to long-term postoperative outcomes in older
AHR patients and, crucially, no studies describe peri-operative QOL changes in older hernia patients
despite the fact that it is a key consideration for AHR patients and their surgeons. Because of the
profound influence QOL gains have on the surgical decision making process, and with the rapid aging of the
hernia patient population, we believe that understanding the relationship of frailty to QOL outcomes after
AHR is essential. We will undertake a retrospective review of prospectively collected data from a national
registry of AHR patients to assess the effect of frailty on patient-reported QOL, as well as standard
postoperative outcomes (such as morbidity, mortality, complications, readmissions) for AHR patients over the
age of 65 (Aim 1). We hypothesize that increasing frailty will confer a dose-dependent risk of adverse
outcomes following AHR, as well as an inverse relationship with quality of life gains. We believe these results
may be used in the future to develop surgical decision making tools for older patients considering elective
AHR. Pre-surgical optimization is especially important in older, frail patients who decide to undergo operative
interventions such as AHR. To that end, we propose to pilot test a novel abdominal wall physical therapy
(AWPT) program in a cohort of older patients undergoing elective AHR at a major tertiary
care center (Aim 2). Hernia patients over the age of 65 will be offered enrollment in an AWPT program
consisting of both home exercises and in-person physical therapy. We will utilize validated measures to assess
the effect of AWPT on both strength (Timed Up and Go Test, Sit to Stand Test) and mobility (Life Space
Assessment) in AHR patients before and after surgery. We will also use semi-structured interviews to
explore older AHR patients’ perspectives on the feasibility and utility of AWPT. We believe that at the
completion of this study we will have a better understanding of how frailty affects QOL gains after AHR and,
additionally, will be able to utilize our AWPT pilot data to undertake a larger trial examining the effects of peri-
operative AWPT on outcomes after AHR in an older cohort.

Public health relevance
PROJECT NARRATIVE Abdominal hernia repair (AHR) is one of the most common elective general surgery procedures performed in the United States, accounting for over 3.2 billion dollars in annual healthcare spending and is increasingly performed in patients aged 65 or older. Currently there is little data regarding the relationships of aging-related conditions, such as frailty, strength, and mobility, to functional and quality of life outcomes after AHR. This study seeks to elucidate the relationship between frailty and quality of life after AHR and also pilot test an abdominal wall physical therapy (AWPT) program in older AHR patients with the hope of utilizing the data to undertake larger, randomized trials in the future.